Clinical Core D

PROJECT SUMMARY – CLINICAL AND BIOSTATISTICS CORE D
The Texas Developmental Center for AIDS Research (D-CFAR) is based at Baylor College of Medicine
(Baylor) and University of Texas Health Science Center at Houston (UTHealth) and the Texas Biomedical
Research Institute (TxBiomed) in San Antonio. A strategic planning process demonstrated need for clinical and
biostatitistical research support among both established and early stage investigators at the home institutions.
The Texas D-CFAR will therefore establish a Clinical and Biostatistics Core (CBC, Core D) to capiltalize on the
resources and expertise of HIV investigators and biostatisticians to facilitate high-impact clinical, translational
and basic science research aimed at Ending HIV and Optimizing HIV Health in Texas. The Core leadership
team has extensive experience in study design, clinical research, and research implementation, and data
management and analysis. It also is well connected with national biobanks and repositories and is thus
positioned to reach and support a diverse array of investigators. Texas D-CFAR investigators and affiliated
users, whether junior or new to HIV research or the participating institutions, may lack knowledge of how to
design, initiate and implement studies; how to obtain or access clinical samples or data; and/or how to design
and execute appropriate and reliable data management and analytic plans. The CBC goal is to fill that gap. To
do this, Core D will provide project development and implementation services for investigators who are junior
or new to HIV research or D-CFAR institutions; provide access to human tissue and blood samples, facilitating
clinical, translational and basic science research; and provide data analysis, data management and
consultative biostatistical services to investigators who are junior or new to HIV research or D-CFAR
institutions. The D-CFAR CBC will stimulate through mentorship and recruitment and facilitate through project
implementation high-impact research, meeting the current and anticipated clinical, translational and basic
science research and educational needs of local investigators, the NIH and our local communities of people
with and at risk for HIV. The Core leadership, in collaboration with the D-CFAR leadership, has identified a
comprehensive action plan, set of activities, policies and procedures and evaluation metrics to ensure success.
Through accomplishing our aims, we will move toward our goal of Ending HIV and Optimizing HIV Health in
Texas and be able to transition to full CFAR funding in 5 years.